Administrative Core

Project Summary: Administrative Core
The Administrative Core is aligned to support the overarching goals of the OADRC: (1) to focus on early
detection of change in order to define mechanisms supporting healthy brain aging and the transition to MCI
and early dementia, with an emphasis on multiple etiology dementia, including both AD and vascular
contributions to cognitive impairment and dementia (VCID), and (2) to facilitate developing effective therapies
to prevent or limit these transitions and strategies to support patients and caregivers living with Alzheimer’s
disease and related dementias (ADRD), including in diverse and other historically under-represented research
populations. Five overall OADRC specific aims are designed to achieve these goals: SA1) Catalyze and
sustain innovative research and discovery in ADRD through an organizational infrastructure supporting a rich
collaborative environment composed of leading edge technologies and methods, multi-disciplinary scientists,
empowered research volunteers, and an inspired community of lay and professional stakeholders, SA2) Focus
the innovation and discovery infrastructure of the center toward specific areas of emphasis, SA3) Provide the
necessary materials to support the science through well-characterized research participants, biological
specimens, brain tissue, data provision and analytics, SA4) Contribute to the national research commons, and
SA5) Provide venues and mechanisms for education and training of new scientists, as well as bidirectional
engagement with key stakeholders. The OADRC Administrative Core provides oversight, management and
quality assurance for these overarching goals and overall Specific Aims, and all other Center activities. It acts
as the lead unit in strengthening and improving links between scientific and appropriate lay community leaders
and organizations, locally and nationally. The Administrative Core Specific Aims are to: 1) Coordinate and
integrate the individual core units and resources of the OADRC and their interactions with each other, as well
as with individual scientists, clinicians, educators and the community; 2) Oversee and monitor directions and
interactions of the Center, setting relevant goals and optimizing resource utilization, with a commitment
towards enhancing diversity across our research, clinical, and educational pillars; 3) Perform ongoing, regular
review of progress to ensure each unit within the OADRC performs to standards of highest quality and
productivity while operating in strict compliance with human participants, animal welfare, scientific integrity, and
financial policy requirements of the university and NIH; 4) Provide a structure and forum to foster and develop
new and innovative research in brain aging ADRD, including administration of Developmental Projects and
oversight of REC training; 5) Facilitate collaborative research, scientific interactions, and data sharing transfer
with other Alzheimer’s Disease Research Centers, the National Alzheimer’s Coordinating Center, the
Alzheimer’s Clinical Trials Consortium, the National Centralized Repository for Alzheimer’s Disease, the ADRC
Consortium for Clarity in ADRD Research Through Imaging (CLARiTI), and other relevant research groups.